Identification and Development of Small Molecule Orthopoxvirus Inhibitors

To identify and develop small molecule inhibitors targeting orthopoxviruses via a mechanism of action distinct from current available drugs.